Wyoming INBRE Bioinformatics Core

Bioinformatics Project Summary
The long-term goal of the Bioinformatics Core (BC) is to develop a robust bioinformatics
infrastructure that increases the overall research productivity of Wyoming researchers, and
provides career-enhancing training for Wyoming students. The primary goal of the BC during
INBRE 4 is to build on successful bioinformatic programs supported by previous INBRE funding
with a plan that acknowledges the state’s needs and takes into account the unique structure of its
INBRE network. The BC will pursue the following three objectives to achieve this BC-specific goal,
as well as the overall Specific Aims of Wyoming INBRE 4:
1. Support bioinformatics research and education at the University of Wyoming, by enhancing
and extending successful INBRE 3 programs.
2. Foster statewide development of bioinformatics skills and capabilities through support for
research and training at the community colleges and state entities.
3. Expand the impact of the BC’s work through engagement with regional and national INBRE
programs and networks.
The expected outcomes of the BC include successful collaborative bioinformatics research
projects, which at the University of Wyoming will generate publications in the peer-reviewed
literature, and at the community colleges will provide student exposure to bioinformatics
methodologies. Bioinformatics education will continue to support the transition of research groups
to being capable of independent bioinformatic analysis. Tangible resources in the form of seed
grants for data generation, as well as travel grants to acquire specialized bioinformatic training,
will position Wyoming investigators to compete successfully for extramural research funding. BC
personnel will also contribute to a burgeoning UW undergraduate curriculum in computational
biology and data science, through teaching of dedicated bioinformatics courses. Outcomes of
work with state entities will include continued support in data analysis training as well as an
internship program to improve workforce development. These project outcomes will have positive
impact on the ability of Wyoming researchers and educators to use bioinformatic approaches in
their research, and on career trajectories and workforce development for student and state entity
trainees. To help achieve these objectives, we propose two improvements in BC organizational
structure and staffing. The BC Director will be assisted by a new BC Associate Director, and
addition of a new Bioinformatics Education and Outreach Coordinator to enhance the BC’s ability
to support community college and UW faculty to add bioinformatics modules into existing courses.